Analytical Integration of Lipoprotein Lipidomics

STUDY SUMMARY/ABSTRACT:
The cardiovascular research community has established strong correlations between the plasma
concentrations of atherogenic apoB-containing lipoproteins (apoB-Lps) and the clinical risk of cardiovascular
disease (CVD). More detailed analyses are now uncovering additional predictors of risk for CVD within these
particles (e.g., the content of apoC3 and ceramides). The goal of this study is to incorporate bioinformatics/
biostatistics analytic approaches on novel lipidomic and proteomic targets to draw correlations to
cardiometabolic markers. Samples from the parent grant provide internal data sources and analytes for data
curation and analysis, specifically non-parametric modeling, and Spearman partial correlation. The use of a
robust measurement tool for novel lipidomic and proteomic metrics presents promising outcomes for
translational research. In the realm of population health, the understanding of confounding through frequency
counts will help in accounting for spurious associations for obesity pharmacotherapy in New York sampled
bariatric surgery populations. Additionally, these relationships can be properly conditioned after being
identified. For aim 1, persistent significance and network analysis will be included. For aim 2, a parametric
approach will be taken with significance testing and an alpha of 0.05. Regular communication with C2 core
members and monthly PPG meetings will be attended to keep track of progression.

Public health relevance
PROJECT NARRATIVE This diversity supplement request for Mr. Christian Pacheco aims to provide mentorship, training, and research experience via parent study, titled Biogenesis and Catabolism of Atherogenic Lipoproteins (P01 HL160470-01A1 5700) and Core 2: Human Tissues, Lipidomics, and Proteomics Core led by Dr. Jose O. Aleman.